NOVEL APPROACH TO SELF MANAGEMENT OF ASTHMA IN CHILDREN

DESCRIPTION (Adapted from the Applicant's Abstract): Asthma represents one of the most important chronic diseases of childhood in terms of its impact of normal childhood development as well as expense to parents and the health care system. Self management is seen as an integral part of the care of asthma, and novel methods to reach children are needed.This proposal taps the talents of a group of professional artists and writers with a long time experience in both educational and entertainment industry who will develop, with guidance from a group of experienced asthma specialists, an attractive educational comic book on asthma management. The information contained in the publication will provide children aged 7 to 12 with information to help prevent and control exacerbations of their disease. To evaluate the success of this publication children with and without asthma will be assessed by small group interviews to judge the comprehension and acceptability of the material. Following distribution of the publication, acceptability and knowledge gained will be assessed by parental questionnaire and efforts to assess reported changes in the homes of children with asthma. This effort is looked upon as Phase I project that will lead to the development of an 18-24 minute video that can be used both in health care provider settings or, for nominal cost, in the child's individual video at home.